Investigating the mechanism of ITGA4/6-mediated chemoprotection of ALL cells

DESCRIPTION (provided by applicant): Acute lymphoblastic leukemia is the most common childhood cancer and the 10th most common adult cancer in the United States. Drug resistance remains a major problem in the treatment of acute lymphoblastic leukemia (ALL). The bone marrow (BM) environment, consisting of endosteal and perivascular niches, has been shown to promote cell adhesion-mediated drug resistance (CAM-DR) in leukemia cells. Incomplete response to chemotherapy results in persistence of resistant clones and minimal residual disease (MRD). The exact mechanisms for CAM-DR leading to MRD and approaches to address this problem remain elusive. Integrin α4 mediates adhesion of hematopoietic cells onto bone marrow cells and has been implicated in CAM- DR of leukemia cells. We have determined that integrins α4 and α6 are the most upregulated integrins in pre-B ALL. We hypothesize that α4 and α6 integrin-mediated adhesion of ALL cells to bone marrow stromal niches contributes to the persistence of MRD. Integrin α4 and α6 loss-of-function studies in a BCR-ABL1+ pre-B ALL mouse model resulted in loss of adhesion, increased chemo-sensitivity and decreased self-renewal capacity of ALL cells. Using FDA approved Natalizumab as α4 blocking antibody, we demonstrated in a xenogeneic ALL model that α4-blockade with chemotherapy can eradicate leukemia. Delineating the mechanistic basis for this concept will enable us to validate and further develop this treatment approach towards patient care.

Public health relevance
PUBLIC HEALTH RELEVANCE: Acute lymphoblastic leukemia is the most common childhood cancer and the 10th most common adult cancer in the United States. Resistance to chemotherapy and resulting relapse of the disease remains a major problem. This project investigates the bone marrow and leukemia interactions to overcome drug resistance and focus on validating preclinically targeting integrin-mediated adhesion as a new adjuvant therapy in ALL.